Core A - Resource for Clinical Studies of AKI

Project Summary
Clinical and translational research in acute kidney injury (AKI) requires access to well characterized
patients with longitudinal follow up coupled with biological samples enabling investigators to probe the
underlying mechanisms and pathways contributing to outcomes. The specific aims of the Resource for Clinical
Studies of AKI (Core A) are to (i) facilitate and support the design and conduct of clinical research in AKI with
appropriate tools to collect and record information for detailed phenotypic characterization of patients through
the course of AKI, (ii) provide access to comprehensive datasets of well characterized patients with and
without AKI, and (iii) provide a biological sample repository that includes human kidney tissue, blood and urine,
linked to an accessible clinical database of patients with and without AKI to enable translational research
studies. This core will specifically provide investigators access to patients with AKI through an established
international network of collaborating investigators who are contributing to an ongoing registry of AKI in the ICU
setting currently with over 2,200 patients. Core A is designed to facilitate both hypothesis-driven and
hypothesis-generating clinical research by providing essential resources for clinical investigation and
enhancing interactions with a large worldwide network of investigators and centers focused on AKI.
Since its inception the Core has been very successful in supporting investigators for clinical and
translational research. We have established a robust data management system and database of patients with
AKI that is flexible in accommodating the research objectives of individual investigators and collaborating
centers. A new service being offered by Core A is the addition of human kidney tissues along with biological
samples (blood, urine and DNA) from patients with and without AKI and healthy controls. Over the last 4 years,
Core A has been highly productive in assisting multiple facets of clinical research supporting 72 investigators
including 8 pilot and catalyst awardees and 111 different projects. These combined efforts have resulted in 40
peer-reviewed publications. All services provided by Core A are being utilized by our investigator base. We
envision that these rich resources will continue to enable interdisciplinary clinical investigation in AKI to
advance our understanding of the natural history and pathophysiology of human AKI. We are confident that
Core A in conjunction with the existing resources at UAB and UCSD and other cores within the O'Brien Center
will accelerate the translation of new investigative insights towards improving outcomes for patients with AKI.